The Impact of Cognitive-Motor Interference on Balance Control in Children with Cerebral Palsy

PROJECT SUMMARY / ABSTRACT
Cerebral palsy (CP), the most common cause of childhood disability, results from a non-progressive
disturbance to the developing brain and leads to impairments which negatively impact mobility and function.
Individuals with CP demonstrate abnormal reactions to anticipated (proactive) and unanticipated (reactive)
balance challenges, placing them at increased risk of falls. Adults with CP are 3.64x more likely to fall than
their typically developing peers, and the incidence of falls in children with CP is similarly increased. Balance
control is worsened with the addition of a secondary (dual) cognitive task. This causes cognitive-motor
interference, which results when motor and cognitive tasks are competing for the same resources and leads to
degradation in performance of one or both tasks. These cognitive-motor tasks mimic daily life situations such as
walking and talking with friends, and the difficulty that children with CP experience in these situations leads to
declines in participation and function. Previous work has investigated this cognitive-motor dual task paradigm;
however, all studies have utilized proactive balance challenges, with the primary motor tasks of balance or
straight path ambulation. Evaluation of a more functional proactive balance task, such as obstacle negotiation,
is needed in the context of a cognitive-motor dual task situation. Additionally, previous studies have shown that
children with CP fall more and have decreased stability during single task reactive balance challenges; however,
this single task condition requires the addition of a secondary task to become functionally relevant and mimic
daily life scenarios. Our specific aims will address these mechanistic and participatory gaps in the literature by
investigating: (1) proactive balance control through negotiation of an overground obstacle in single and dual
task conditions, in children with CP compared to TDC; (2) reactive balance control through stance slip-like
treadmill induced perturbations in single and dual task, in children with CP compared to TDC; and (3) the
correlation between balance control and participation in mobility-related habits of daily life in children with
CP utilizing the LIFE-H, linking the biomechanical and mechanistic laboratory findings (Aims 1 +2) to participation
and quality of life (Aim 3) for children with CP. We hypothesize that children with CP will demonstrate decreased
stability and greater falls in both single and dual task conditions when compared to TDC, and that both groups
will experience these declines in performance, when compared to themselves, in dual task conditions. The
results from this study will be integral in establishing the mechanisms underlying balance control during functional
proactive and reactive balance challenges, and how this stability correlates with overall mobility-based
participation for children with CP. This will provide valuable insights for developing effective clinical interventions
and improving the quality of life and participation of children with CP. The findings will contribute to the design of
future research paradigms and facilitate the translation of intervention strategies into clinical practice.

Public health relevance
PROJECT NARRATIVE Due to abnormal responses to both expected and unexpected balance challenges, children with cerebral palsy are at an increased risk of falls and resulting injuries. This study will investigate how children with cerebral palsy respond to expected and unexpected balance challenges which mimic functional, daily-life scenarios, and how these responses change with the addition of a secondary, cognitive task. The findings from this study will inform the development of future research studies and facilitate the translation of intervention strategies to clinical practice, improving mobility-based participation and function for children with cerebral palsy.